HPGRF TEST TO DEFINE GH RESERVE IN CHILDREN WITH GH DEFICIENCY

Purpose is to determine the effect of hpGRF given using 1.5 times ED100 dose of hpGRF as a bolus and to develop of hpGRF test to define GH reserve in children with GH deficiency and/or short stature.